Leveraging access to parasite natural diversity to identify Plasmodium vivax culture-adaptable strain.

Plasmodium vivax (Pv) poses a significant challenge due to its extensive geographical distribution, resulting in
a considerable burden of morbidity and mortality in regions where it is endemic. Diverging from Plasmodium
falciparum (Pf), Pv manifests distinct characteristics, notably the presence of dormant liver stages and the
inherent impediment to in vitro cultivation. These peculiarities present formidable obstacles to Pv malaria
elimination. The development of a robust and reproducible in vitro culture system for Pv would be a game-
changer to design efficacious anti-malarial strategies. The Phase I of our project aims to establish robust and
long-term stable in vitro cultures of Pv clinical isolates. Our main advantage lies in having access to multiple
clinical isolates thanks to our mobile laboratories installed in endemic regions of Cambodia, at the bedside of
infected patients. This infrastructure enables us to systematically conduct in vitro culture tests on several hundred
fresh and healthy Pv strains. This initial approach will facilitate the selection of Pv strains possessing a genetic
background adapted for in vitro culture. The second part of the project will investigate optimal culture conditions,
including, but not limited to, culture medium composition or impact of different concentrations of O2 and CO2 on
in vitro survival of Pv using a specifically designed hypoxic chamber. We will explore hematopoietic stem cells
as sources of reticulocytes and assess the potential of human mesenchymal stromal cells as support cells for
Pv survival in vitro. Finally, we aim to establish a 3D organoid model capable of reproducing the specific
conditions of the bone marrow, recognized as a primary site of Pv development. The third part of the project will
utilize strains with the highest potential for in vitro culture to investigate the in vitro modification of Pv genome
using Crispr Cas9. As a proof of concept, we will insert a gene encoding GFP. Regarding the Phase II of the
project (R33) we will employ the genetic modification method developed in Phase I to establish different strains
of genetically modified Pv. This aims to study various mechanisms of drug resistance and identify potential
resistance markers. Our objective includes the study of the overexpression of the PvCRT or PvMDR1 genes and
the expression of the V552I and Y976F variants in the Pvkelch12 and PvMDR-1 genes, respectively in order to
explore resistance to the main drugs currently used in Pv treatment. This study has the potential not only to
provide tools for a better understanding of Pv biology but also to identify potential drug resistance markers crucial
for current malaria control strategies.

Public health relevance
The lack of an in vitro culture system for Plasmodium vivax (Pv) has significantly impeded the progress of various essential studies crucial for advancing our understanding and combating malaria. Leveraging our proximity to infected patients in Cambodia, we propose (i) a systematic examination of various Pv clinical isolates to identify culture-adaptable genotypes, (ii) a rigorous evaluation of culture conditions and (iii) to investigate the potential role of mesenchymal stem cells (MSCs) in Pv development. This comprehensive investigation will enhance our understanding of Pv biology and facilitate the development of crucial tools for studying drug resistance and devising anti-Plasmodium vivax strategies.